Identification of the protein:protein interactions of a non-nuclear NFKB that modulates ethanol sensitivity.

Project Summary/Abstract. Neuroimmune signaling through TLR (Toll-like-receptor) pathways modulate
ethanol behaviors in mammals and flies. An output of these pathways are NFκB transcription factors. The fly
NFκB gene called Dif is an output of the Toll signaling pathway in adult flies. Dif modulates ethanol sensitivity—
increased Dif activity reduces sensitivity, while decreased Dif increases sensitivity. Because NFκB is a well-
known transcription factor, it has been axiomatic that its effects are produced by an action in the nucleus. In
addition to the well-known nuclear and cytoplasmic locations, NFκB has also been observed at the postsynap-
tic density. In mammals, synaptic activity has been described as causing the translocation of NFκB from the
synapse to the nucleus where it modifies gene expression in ways that alter synaptic plasticity. However, from
Drosophila there is strong evidence that NFκB proteins can directly modulate the synaptic machinery. The Dif
gene produces two NFκB protein isoforms by alternative mRNA splicing. These are DifA and DifB. The focus of
this proposal is DifB. The DifB isoform is only expressed in Drosophila CNS neurons, where it is specific to the
mushroom bodies (well known to influence ethanol behaviors), antennal lobes, and the subesophageal gan-
glion of the brain. The DifB isoform lacks a nuclear localization signal and a transcription activation domain.
DifB biochemically co-fractionates with a synaptic protein and away from a nuclear protein. Immunohistochemi-
cal staining confirms that DifB localizes to synaptic regions but does not enter the nucleus even following im-
mune activation. Splice variant–specific mutations show that the DifB isoform modulates the sensitivity to seda-
tion with ethanol but does not contribute to immunity. Whereas the nuclear DifA isoform is essential in the
immune response but does not contribute to the ethanol response.The objective of this proposal is to
identify DifB interacting proteins in order to better predict how DifB modulates ethanol sensitivity. We
have used CRISPR to build flies that express a variety of epitope-tagged DifB (& DifA) isoforms. These will be
used in coimmunoprecipitation/mass spectrometry experiments to identify proteins that physically interact with
DifB. Based on biochemical fractionation, imaging, and evolutionary comparison with a related protein, we ex-
pect the interacting proteins to be synaptic proteins. The extragenomic action of an NFκB is an unexplored and
rapid way in which Toll pathway signaling can modulate ethanol responses. The description of the protein:pro-
tein interactome of the extragenomic NFκB encoded by DifB will be a significant contribution because it will
provide us with the keys for understanding how this protein modulates neuronal signaling and behavior. Fur-
thermore, understanding how an NF-kB can directly modulate the synapse may also contribute to our under-
standing of the origins of the unusual consequences of neuroimmune dysregulation such as impaired brain
function, the exacerbation or cause of mental illnesses, and neurologic complications of Covid-19 disease.

Public health relevance
Project Narrative. In the United States, ~5% of the population have an alcohol-use disorder and alcohol mis- use is the third leading preventable cause of death. The exploration of how a neuron-specific, nonnuclear NFkB mediates alcohol responses needs to be explored because it provides a novel way for neuroimmune signaling to mediate the response of the nervous system to alcohol. Furthermore, understanding how an NF- kB could directly modulate synaptic activity may also contribute to our understanding of the origins of the un- usual consequences of neuroimmune dysregulation such as impaired brain function, the exacerbation or cause of mental illnesses, and neurologic complications of Covid-19 disease.